Intersectionality Scientific Working Group

PROJECT SUMMARY FOR INTERSECTIONALITY SCIENTIFIC WORKING GROUP
The overarching goal of the Intersectionality Scientific Working Group (SWG) in the UCSF Bay Area CFAR is
to develop and advance multidisciplinary applications of the critical framework of intersectionality to HIV and
related health disparities research. Intersectionality is a critical theoretical and normative framework that
elucidates how structural forms of power and privilege intersect to create and reinforce social
inequalities. An intersectional lens provides a framework through which to design studies and analytic
approaches to examine the structural drivers of HIV and related health disparities. The Intersectionality SWG
will develop and advance intersectional approaches to research by: (1) providing scientific leadership and
community building around the development and application of emerging intersectionality methods to HIV and
health disparities research, (2) promoting collaborative, multidisciplinary, and community-engaged research
using intersectionality as a framework to address HIV and health disparities, including support for identification
and dissemination of – as well as applications for – relevant funding opportunities, (3) facilitating training and
mentoring in intersectional approaches to HIV health disparities research. The Intersectionality SWG goals are
to: host 10 monthly meetings/year (with breaks in July and December) alternating between a journal club,
works in progress workshops, and biannual scientific forums jointly held with the CFAR Housing SWG;
facilitate 6 writing groups/year resulting in 3 publications/year by Intersectionality SWG members that apply an
intersectional framework to HIV and health disparities research; launch an interactive Intersectionality Learning
Center to facilitate the formation of intra- and inter-CFAR research collaborations, amplify intersectionality-
focused publications, and disseminate information on intersectionality-focused funding opportunities; promote
the incorporation of an intersectional lens into work of the CFAR Cores; develop and implement a module on
intersectional approaches to mentoring for the CFAR Mentoring the Mentors workshop; host an annual full-day
workshop highlighting intersectionality-focused research from UCSF-Bay Area CFAR researchers and invited
guests; and increase the number of underrepresented minority (URM) early stage investigators (ESIs)
conducting intersectionality research and support applications for CFAR mentored-scientist research
funding and NIH calls for applications relevant to intersectionality. The Intersectionality SWG will work
closely with the Housing SWG and other Cores, including the Bio-Behavioral Core with its PrEP cohort,
Substance Use Research Program, and Biomarkers of Behavior Program. We will also explore interest in
and feasibility of establishing an Inter-CFAR Working Group on intersectionality. Membership will
include and attract multidisciplinary researchers with diverse expertise to a highly interactive and engaged
Intersectionality SWG within the UCSF Bay Area CFAR.